Elucidating the Dynamics and Function of Long-Range Polycomb Interactions

Project Summary/Abstract
Precise spatiotemporal regulation of gene expression is fundamental to biological function. Polycomb-
group proteins (PcGs) are critical regulators that establish and maintain repression of developmental genes.
Polycomb proteins are conserved across multicellular eukaryotes and are essential in mammals, in which their
deletion causes embryonic lethality or developmental defects. However, how the Polycomb system drives
repression of target genes and how cell type-specific Polycomb genes are selectively derepressed during
development remain unknown. PcGs form two distinct complexes, Polycomb repressive complex 1 and 2 (PRC1
and PRC2), which modify chromatin and mediate 3D interactions between Polycomb-bound regions. PcG
binding and histone modifications alone are insufficient to explain Polycomb repression, suggesting a functional
role for 3D chromatin interactions. In particular, long-range looping interactions between distal Polycomb loci
appear to be functionally important, as they are observed in both flies and mammals and disappear during
differentiation. Yet, the dynamics of these interactions, including whether they are frequent enough to drive gene
silencing, and how they contribute to changes in gene expression during development remain unclear.
The proposed research will examine the dynamics and function of long-range Polycomb interactions in
gene repression by combining cutting-edge super-resolution live-cell imaging, genomics, polymer simulations,
and perturbations. Existing methods relying on cellular fixation cannot capture the inherently dynamic nature of
these processes. I will therefore directly visualize Polycomb loops, target genes, and nascent transcription. Aim
1 will address whether the interactions are stable and frequent enough to confer function, determine chromatin
organizing principles that drive loop formation, and directly test the impact of abolishing Polycomb looping on
gene expression. In Aim 2, I will determine whether changes in long-range Polycomb looping dynamics
correspond to gene activation by simultaneous imaging of Polycomb target genes and nascent transcription.
These studies will be complemented with genomics approaches to address genome-wide features that correlate
with selective derepression of developmental genes. Together, the proposed research will define the functional
relationship between distal Polycomb interactions and transcriptional regulation, revealing whether long-range
3D chromatin interactions represent a key mechanism of Polycomb-mediated gene repression. These studies
will inform our understanding of how cells are able to precisely control gene expression during development and
provide a basis for future studies to correct disrupted Polycomb regulation in disease.
The proposed research is designed to provide the necessary conceptual and technical training to achieve
my goal of becoming an independent PI at a research institution. Research training will be conducted in parallel
with career development training to develop necessary skills to establish and lead a research lab, including
training in the responsible conduct of research, scientific communication, leadership, and lab management.

Public health relevance
Project Narrative The Polycomb repressive system is essential for proper regulation of gene expression and its dysregulation leads to cancer and developmental defects. Yet, how this system establishes repression of target genes and how these genes are derepressed in the correct spatiotemporal context during differentiation remain unknown. The proposed research will use a multidisciplinary approach to reveal whether and how long-range 3D chromatin interactions contribute to Polycomb-mediated gene repression, providing valuable insights into how cells are able to precisely control gene expression during development and how disruption of Polycomb regulation leads to human disease.